Building Interdisciplinary Research Careers in Women's Health at UC Davis

In the past 19 years, the UC Davis BIRCWH program has trained a sizeable, diverse group of interdisciplinary researchers in women's health and sex differences, elevating the prominence of this research. Building on this strong foundation, our next-generation BIRCWH program, led by Dr. Nancy Lane, will enhance innovation and impact. We aim to foster an academically stimulating environment that promotes career development and encourages paradigm-shifting, interdisciplinary collaboration, and team science to advance research in women’s health and sex disparities. Our short-term BIRCWH objectives are to: 1) provide indepth, individualized training and team-based interdisciplinary mentoring to support the independent career development of scholars in interdisciplinary women’s health and sex differences research; and 2) advance and achieve high-impact research in women’s health by establishing cross-disciplinary collaborations with UC Davis schools that advance science and health. Our long-term objectives, in concert with the ORWH 2024-2028 strategic plan, are to: 1) improve women’s health by enhancing understanding of the unique aspects of female sex and translating this knowledge to inform clinical practice; 2) develop transformative interdisciplinary team science for women’s health research and sex differences; and 3) train a diverse group of leaders in interdisciplinary women’s health and sex differences research. To accomplish our objectives, BIRCWH scholars will participate in: 1) team-based, interdisciplinary mentored research and career development activities; 2) core courses on study design, grant writing, biostatistics, team science and responsible conduct of research; 3) courses tailored to each scholars’ needs and interests including K award and R01 grant writing courses; 4) team-based interdisciplinary research; 5) integrated journal clubs; 6) monthly meetings with the PI and RDs to discuss research and career progress; 7) a biannual symposium of Northern California BIRCWH programs; and 8) the School of Medicine (SOM) Mentoring Academy, for mentors and scholars to be trained in skills to optimize mentoring experiences; 9) Office of Research in Women’s Health zoom seminars on women’s health and career development. Our program will leverage campus expertise in four research areas: neuroscience/pediatric neurodevelopment/ behavior; metabolic/inflammatory/nutrition-related syndromes; musculoskeletal diseases and aging disorders; and cancer/pain. These areas will be addressed through our BIRCWH crosscutting themes: 1) a lifespan approach to understanding normal development, illness/disease, and aging; 2) sex differences and 3) interdisciplinary research. This K12 program will fund four scholars and we have funding commitment from the SOM for a fifth scholar. All BIRCWH scholars must be junior faculty within six years of their terminal degree and must engage in interdisciplinary women’s health and/or sex differences, team science-based research and create an independent development plan for their pathway to independence.

Public health relevance
In this competitive renewal of the UC Davis BIRCWH program (PI, Dr. Nancy Lane), we propose to build on the experience and achievements of our previous 19 years of the program to advance, promote, and achieve interdisciplinary training and mentoring of team-based science for the next generation of researchers in women’s health and sex differences. Our diverse BIRCWH faculty, mentors, and scholars will work to improve the health of women and increase our understanding of the mechanisms and manifestations of sex differences in health and disease to improve the health and well-being of our communities.